The role of metal ion homeostasis in regulating bacterial capsule production

Project Summary/Abstract
Capsular polysaccharide (CPS) produced by pathogenic bacteria is a key virulence determinant for
bacterial survival in the human host, but knowledge of how CPS production is regulated remains limited. Given
the need for pathogenic bacteria to modulate CPS expression (thickness) among various host niches during
disease progression, we postulate here that available environmental factors such as metal ion micronutrients
can influence CPS production. The long-term goal is to help develop alternative metal-based antimicrobial
therapeutics for clinical treatment of bacterial diseases in humans. The overall objectives in this application,
which constitute the first step toward attainment of the long-term goal, are to identify the molecular
mechanisms by which cellular metal ion ratios, specifically manganese (Mn), zinc (Zn), and calcium (Ca),
influence CPS production, while increasing exposure of undergraduates to research and enhancing Idaho
State University’s biomedical research enterprise. The central hypothesis is that metal ion micronutrients
regulate CPS biogenesis via direct modulation of enzyme activity in pathogenic bacteria using Streptococcus
pneumoniae (Spn) as a Gram-positive model bacterium. The rationale for this project is that a mechanistic
understanding of how cellular metal ion ratios regulate CPS expression levels would provide new opportunities
for the subsequent identification and development of targets for the design of novel interventions to treat
human pathogenic bacterial infections. To attain the overall objectives, we will pursue the following specific
aims: 1) Identify the mechanism(s) whereby bioavailable Mn/Zn ratios affect CPS production; and 2) Determine
the role of Ca in Mn homeostasis and CPS biogenesis. The first aim will assess the physiological and
biochemical impact of bioavailable Mn/Zn ratios on several Mn-utilizing enzymes involved in various arms of
the Spn CPS biosynthetic pathway. The second aim will assess the impact of Ca/Mn ratios on the intracellular
metal landscape and CPS biosynthesis in coordination with RNAseq and proteomic analysis. The overall
approach combines classical microbiology techniques with modern day applications that span the interface of
biology and chemistry, thereby exposing undergraduates to interdisciplinary research techniques. The
research proposed in this application is innovative, in the applicant’s opinion, because it represents a
substantive departure from the status quo by focusing on the impact of overall cellular metal ion micronutrient
ratios and their capacity to regulate bacterial CPS biogenesis. The research proposed will also further the
understanding of how cellular metal ion availability serve as signaling factors that influence global cellular
changes and cellular programing during pathogenesis. The proposed research is significant because it is
expected to provide a strong foundation for subsequent future design of mechanistic and alternative metal-
based drug development strategies to combat human bacterial pathogens prone to exhibiting multidrug
resistance.

Public health relevance
Project Narrative The proposed research is relative to public health because it focuses on defining the mechanisms by which metal ion micronutrients regulate capsular polysaccharide, a major virulence factor of human pathogenic bacteria that are prone to developing multidrug resistance and remain particularly dangerous in young children and older adults. Once such mechanistic and molecular determinations have been established using Streptococcus pneumoniae as a Gram-positive model bacterium, there is potential to advance towards the subsequent design of mechanistic and alternative metal-based drug development strategies to combat human bacterial pathogens, all while increasing undergraduate exposure to research and enhancing Idaho State University’s biomedical research enterprise. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to reducing illness in the human population and aligns with part of the NIAIDs mission that pertains to better understanding infectious diseases at the pathogen level so that new therapeutic treatments can be developed.